Therapeutic Targeting of RNA Splicing in Triple-Negative Breast Cancer

Triple-negative breast cancer (TNBC) is an aggressive subtype of breast cancer that is recalcitrant to
molecular targeted therapies and accounts for about 200,000 new diagnoses per year worldwide.
Immunomodulators, therapies that harness the immune system against cancer, have revolutionized the
treatment of some cancers and have recently been approved for treatment of TNBC. Disappointingly, TNBC
patient response to these therapies has been heterogeneous and significantly lower than other types of cancers.
TNBCs are notoriously immunologically cold, with relatively low levels of baseline immune infiltration
limiting the efficacy of immunomodulators that amplify productive antitumor immune response. Therefore, a great
deal of effort has been focused on promoting immune engagement in these tumors. We have previously shown
that oncogenic aberrations common in TNBC result in hypersensitivity to perturbation of the RNA splicing
machinery. Importantly, multiple studies, including our own (Bowling, Wang, et al. 2021), have revealed that
therapeutic efficacy of spliceosome-targeted therapies (STTs) is in part due to engaging the host immune
system. While these discoveries hold great promise for clinical deployment of STTs, especially in combination
with immunomodulators, several aspects of their role in activation of antitumor immunity require further
understanding. Herein, we propose to interrogate the species of mis-spliced RNA that trigger viral mimicry and
trigger tumor inflammation and antitumor immunity.
Aim 1. Investigate combinatorial therapy approaches based on STT-induced antitumor immune
response. Our preliminary data indicate that activation of tumor-intrinsic antiviral signaling by STT treatment
modifies interaction with the tumor microenvironment. By leveraging a diverse cohort of immune-competent
syngeneic models of TNBC, we will elucidate the STT-induced change in immune infiltrate and evaluate
treatment in combination with immunomodulators to enhance the efficacy of STTs.
Aim 2: Define cellular modulators of endogenous dsRNA-mediated antiviral signaling. Prominent
oncogenic aberrations have been shown to modulate baseline and agonist-induced inflammatory signaling in
tumor cells. Indeed, we have observed heterogeneity in antiviral transcriptional response across a panel of TNBC
cell lines with STT-induced dsRNA accumulation. Thus, we will leverage an interferon reporter-based genetic
screen to identify novel regulators of cell-intrinsic immune response to endogenous dsRNA accumulation.
Aim 3: Evaluate features of STT-induced mis-spliced RNA that stimulate antiviral signaling. Preliminary
studies indicate that distinct chemotypes of STTs being investigated in the clinical setting result in differential
antiviral immune signaling. Using chemical genetic perturbation and novel RNA labeling and sequencing
methods, we will profile immunogenic misprocessed RNA generated by perturbation of distinct spliceosome
components encompassing the entirety of the RNA splicing cycle.

Public health relevance
Project Narrative Our proposal aims to develop new strategies to combat a common and aggressive subtype of human breast cancer (triple-negative breast cancer, or TNBC) through modulation of antitumor immune response. We recently discovered that targeting MYC+ TNBC with spliceosome-targeted therapeautics (STTs) triggers a form of viral mimicry, where mis-spliced RNAs trigger a double-stranded RNA antiviral program. Herein, we propose to elucidate the molecular and cellular mechanisms of this STT-induced antiviral signaling and harness the resulting immune response as a therapeutic approach for TNBC.